Prolactin monoclonal antibodies (PRL-mAbs) for the treatment of female-predominant pain syndromes

ABSTRACT: Women are disproportionally impacted by functional pain syndromes (FPS), a large subgroup of
pain conditions defined by the absence of a clear etiology or tissue injury. These syndromes have a high
female:male prevalence ratio and include, but are not limited to, temporomandibular joint and muscle disorders
(TMJD) (9:1 ratio), fibromyalgia (9:1 ratio), irritable bowel syndrome (IBS) (3:1 ratio), and migraine (3:1 ratio), as
well as female exclusive FPS such as dysmenorrhea, endometriosis and vulvodynia.
Reasons for the sexually dimorphic prevalence in FPS remain uncertain but emerging evidence suggests that
prolactin (PRL) elicits sensitization of female nociceptors. PRL selectively promotes hyperalgesia and pain in
female mice with minimal effects in male animals. PRL signals through mutually inhibitory long- and short-form
PRL receptor (PRLR) isoforms that are expressed at higher levels in female nociceptors. Female animals and
humans have higher circulating PRL than males. A role for circulating PRL was demonstrated by prevention of
opioid-induced hyperalgesia (OIH) selectively in female mice by cabergoline, a dopaminergic D2 agonist which
inhibits PRL release from the pituitary. Similarly, migraines associated with PRL-secreting tumors are treated
with D2 agonists. Collectively, these data support that PRL selectively promotes female hyperalgesia.
Our team now wishes to translate these breakthrough findings into novel and transformative therapeutics for
female-prevalent pain conditions. We propose to develop PRL monoclonal antibodies (PRL-mAbs) as first-in-
class therapeutics for female FPS, targeting migraine as the primary indication.
The specific goals of this SBIR Phase I application are to (i) assess the technical feasibility of the program (i.e.,
identification of neutralizing PRL-mAb leads) and (ii) validate the working hypothesis (i.e., demonstration that
systemic administration of a neutralizing PRL-mAb selectively prevents PRL-induced female hyperalgesia in a
migraine relevant model).
Impact and

Public health relevance
PROJECT NARRATIVE: Peptide Logic is developing prolactin monoclonal antibodies (PRL-mAbs) as first-in- class therapeutics for the treatment of female-prevalent functional pain syndromes (FPS), targeting migraine as the primary indication. PRL-mAbs are designed to prevent PRL-induced sexually-dimorphic hyperalgesia in injury-free pain conditions, an emerging but still untapped nociceptive mechanism. If successful, PRL-mAbs have the potential to profoundly transform the standard of care for the treatment of female-prevalent FPS and improve the quality of life for many women.